The role of interleukin 22 in West Nile virus pathogenesis in mice

DESCRIPTION (provided by applicant): This proposal is to characterize the role of interleukin 22 (IL-22), a member of the IL-10-related cytokine family, in the pathogenesis of West Nile encephalitis using a mouse model. IL-22 has been implicated in both chronic inflammatory diseases and infectious diseases. On one hand, IL-22 contributes to pathogenesis of psoriasis and multiple sclerosis. On the other hand, IL-22 protects the liver from immune system-mediated damage during hepatitis, helps maintain epithelial barriers and induces secretion of anti-microbial peptides by the epithelia in response to extracellular pathogen infection, such as K. pneumoniae. However, to our best knowledge, the in vivo role of IL-22 in viral infections remains largely elusive. West Nile virus (WNV) is a neurotropic ssRNA flavivirus that has caused over 1000 deaths in the United States since 1999. However, no human vaccines or specific therapeutics are available. Interestingly we have recently shown that IL-22 does not influence the innate immune response and WNV propagation in the peripheral system, but facilitates the pathogenesis of West Nile encephalitis. We hereby propose to test the prophylactic/therapeutic potential of IL-22 antagonists and hypothesize that IL-22 promotes WNV entry into the central nervous system. Specifically we will 1) test the prophylactic/therapeutic potential of IL-22 soluble receptor IL- 22BP and neutralizing antibodies, and 2) Investigate the mechanism by which IL-22 contributes to WNV pathogenesis. If successful, these studies may lead to new strategies for the prevention of West Nile virus infection. This paradigm would also be applicable to other neuroinvasive viral pathogens of medical importance like Japanese encephalitis and Saint Louis encephalitis virus.

Public health relevance
West Nile virus has caused over 1000 deaths since 1999 in the United States. However, no specific therapeutics or human vaccines are available. This project is to test the prophylactic/therapeutic potential of interleukin-22 antagonists and investigate how IL-22 influences West Nile virus pathogenesis using a mouse model.